Center on the Economics and Demography of Aging

Project Summary/Abstract
Population-based research on Alzheimer’s disease and related forms of dementia (AD/ADRD) requires validated
measures of dementia and mild cognitive impairment that can be compared across populations. The NIA-funded
Harmonized Cognitive Assessment Protocol (HCAP) projects have advanced this measurement by recently
applying common cognitive functioning batteries in Health and Retirement Survey (HRS) family studies in
numerous high-income and low-income countries, building on earlier international comparative efforts such as
the 10/66 Dementia Research Group studies. Yet important challenges remain in interpreting relative
performance on cognitive assessment batteries measured in different cultural settings, as well as their
implications for dementia diagnosis. We propose a supplement to the P30 Center on the Economics and
Demography of Aging (CEDA) to innovatively investigate cross-cultural differences in dementia classification
through the following specific aims: (1) Apply a cutting-edge online clinical consensus dementia diagnosis
protocol in a sub-sample of the NIA-funded Caribbean American Dementia and Aging Study (CADAS), an NIA-
funded HCAP survey in Puerto Rico and the Dominican Republic. (2) Innovatively compare the dementia ratings
by teams of Puerto Rican and Dominican expert dementia clinicians with ratings of the same subjects by
independent teams from the U.S. mainland and from Mexico. (3) Estimate differences in these expert ratings
when using HCAP measures versus those in the earlier widely-used 10/66 studies, taking advantage of the
CADAS design that cross-harmonizes between these approaches in order to understand between-study
differences in dementia prevalence estimation.

Public health relevance
Project Narrative / Statement of Public Health Relevance International comparative research on Alzheimer’s disease and related forms of dementia (AD/ADRD) can greatly advance knowledge of the determinants and consequences of AD/ADRD. In order to realize its potential, however, measures of dementia must be appropriately harmonized across populations with different education levels and socio-cultural contexts. This project will innovatively compare cross-cultural differences in clinician ratings of dementia when interpreting the results of cognitive testing.